Imaging mass spectrometry methodologies for studying the metabolites of cancer metastasis

High grade serous ovarian cancer (HGSC) is the most common and deadliest form of ovarian cancer.
Emerging evidence indicates that these tumors arise in the fallopian tube epithelium (FTE), and thus their
presence in the ovary represents the primary metastasis. Our preliminary data identified that xenografting in
close proximity to the ovary contributes to the aggressiveness of the disease. After ovarian colonization, tumor
cells invade the peritoneal organs, primarily the omentum. We hypothesize that the biological problem of
primary and secondary HGSC metastasis is partially mediated by chemical communication between
the cancer cells and the metastatic organ. Our proposal seeks to define metabolites and biomolecules that
drive the metastasis of fallopian tube derived high grade serous cancers to the ovary and the omentum. To this
end, our teams optimized a 3D co-culture of the ovary and fallopian tube derived tumor models and adapted
this to imaging mass spectrometry technology to identify the metabolomics-driven communication that occurs
during primary colonization of the ovary and during secondary metastasis to the omentum. Using this emerging
technology, we identified several metabolites that enhanced high grade serous tumor migration, invasion, and
adhesion to the ovary. The focus of Aim 1 is to uncover the mechanisms allowing FTE tumorigenic cells to
hijack NE produced by the ovary to increase their ability to invade and adhere to the ovary during primary
metastasis. Aim 1 will define the signaling pathways mediated by NE during invasion and adhesion to the
ovary and then confirm the importance of NE in vivo using both murine and human cell models derived from
FTE. The key adrenergic receptor will be deleted using CRISPR to confirm the importance of this pathway in
metastasis. Tumor bearing models will be treated with beta adrenergic receptor antagonists in an attempt to
translate these findings for a new strategy to block ovarian colonization. The focus of Aim 2 is on the
identification and characterization of a newly identified protein that is secreted from tumorigenic fallopian tube
cells and is responsible for the production of ovarian norepinephrine driving tumor cell invasion and adhesion.
We will use proteomics to confirm the identity of the secreted protein, followed by genetic deletion of the
protein from FTE models to study the role in ovarian colonization. Aim 3 will build upon our existing technology
of 3D organ and tumor cell communication models and expand into secondary metastasis. We have now
optimized our technology for co-culture of the omentum together with tumor cell models and have an inventory
of metabolites, which are unique and did not include norepinephrine. Instead a novel metabolite found to be
produced in significantly more abundance when tumor cells were grown with the omentum corresponded to
folate, the ligand for the folic acid receptor that is overexpressed in the tumor cells. Taken together, our
innovative experimental approach will yield new pathways and targets to mitigate primary metastasis of high
grade serous cancer to the ovary.

Public health relevance
High grade serous cancers arise in the fallopian tube and exhibit a high proclivity to metastasize to the ovary as their primary metastatic site and omentum as a secondary site. Our team developed novel imaging mass spectrometry workflows to interrogate 3D organ culture systems co-cultured with fallopian tube derived tumor models to study the chemical crosstalk that occurs during metastasis. Overall, these data provide important new tools to uncover the signaling that occurs between organs and cells as it relates to the ovarian microenvironment in high grade serous metastasis.